Functional Genomic Dissection of Refractory Anemia

ABSTRACT
Lenalidomide is a highly effective treatment for patients with myelodysplastic syndrome (MDS) with deletion of
Chromosome 5q (del(5q)), with approximately 50% of patients achieving a complete cytogenetic response. In
the previous funding period, we determined the mechanistic basis for the therapeutic efficacy of lenalidomide in
del(5q) MDS, generated the first murine model that responds to lenalidomide, and developed a quantitative mass
spectrometry-based approach to evaluate the activity of lenalidomide and related molecules. We now propose
to investigate the molecular basis for incomplete responses to lenalidomide and acquired resistance, and to
develop a novel therapeutic approach that bypasses resistance. First, we aim to determine mechanisms of
sensitivity and resistance that have not been previously investigated: the impact of lenalidomide on stem cells,
the bone marrow microenvironment, and the immune system. These experiments are enabled by the CRBNI391V
murine model, developed during the previous funding period, that is sensitive to lenalidomide. Next, we will
examine combinatorial targeting of CSNK1A1 and GSPT1 with a new thalidomide derivative, CC-885, and
investigate the mechanism of GSPT1-mediated cytotoxicity in models of del(5q) MDS. Finally, we will investigate
the biochemistry of lenalidomide-dependent degradation of oncoproteins by the CRL4CRBN E3 ubiquitin ligase,
validating genes identified through genome-wide CRISPR screens. These studies will inform the biology of
thalidomide derivatives in general, provide a comprehensive description and mechanistic understanding of
thalidomide derivative effects on immune system homeostasis, and contribute to the development of novel
therapeutics for del(5q) MDS.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndrome (MDS) is a disease of abnormal blood production that frequently progresses to acute leukemia. Heterozygous deletion of chromosome 5q is the most common chromosomal abnormality in MDS. We aim to develop novel therapies for MDS patients with this genetic lesion and to understand mechanisms of drug resistance.